Project 4: Human Ecology (Quality of Life)

ABSTRACT – HUMAN ECOLOGY – PROJECT 4
Cochlear implants (CIs) improve speech recognition for adults with moderate to severe hearing loss; however,
many CI users report significant struggles in their natural listening environments. This is understandable as
speech recognition in complex daily environments are likely to be affected by challenges that are not present in
the sound booth (e.g., high reverberation and accented speech). Indeed, many listeners with CIs report that
difficulty in real-world listening leads to fatigue, stress, and social isolation. CI clinical care has traditionally
focused measures of speech recognition assessed in clinic with the assumption that broader outcomes like
quality of life (QoL) will directly follow. The past literature has shown that lab/clinical measures of speech
recognition are only modestly correlated with QoL, suggesting that the factors that impact speech recognition
in the lab are likely to differ from those that affect speech perception and QoL in CI users’ everyday lives. The
primary goals of the proposed project are to identify challenging listening situations that CI users encounter in
daily life and to examine factors that predict real-world speech perception and QoL over and above what is
measured in the clinic. The study focuses on the role that CI users’ auditory environments, higher order
cognitive skills, and social networks play in real-world listening success and QoL.
The project includes cross-sectional and longitudinal components that combine Ecological Momentary
Assessments (EMA) of real world listening, neuropsychological measures across cognitive domains, and
analysis of individuals’ social networks. Aim 1 will describe the complexity and challenges of auditory
environments encountered in daily life for CI users using objective data collected using ear-level microphones
and self-reports via EMA. We will identify differences in the auditory environment across individuals of varying
age, geographic location, occupational status, and race, and explore the impact of differences in hearing (e.g.,
pre- vs. post-implantation) on the environments one engages in. Aim 2 will identify factors that predict success
with speech perception in the real world (assessed using EMA). This includes data about the auditory
environment collected from Aim 1, and a neuropsychological battery spanning multiple higher-order cognitive
domains. We propose that the auditory environment and cognitive function will explain unique variance in real-
world speech perception, after controlling for the effect of peripheral auditory function and speech perception
measured in the lab. Aim 3 will determine the factors that drive good QoL after implantation. We propose that
speech perception in the real world, higher order cognitive skills, and social network characteristics (e.g., social
support and social integration) will play a more important role in driving QoL than speech perception measured
in the lab.

Public health relevance
PROJECT NARRATIVE – HUMAN ECOLOGY – PROJECT 4 We seek a better understanding of the mechanisms that link changes in auditory function following cochlear implantation (CI) to listening success in challenging real-world environments and quality of life. This has implications to improve CI candidacy decisions, counselling of patients, and post-implantation rehabilitation.